GSH Training Grant

This application requests continued funding for a unique and highly successful predoctoral research
training program, now in its 15th year, located in the Department of Sociomedical Sciences (SMS) at Columbia
University’s Mailman School of Public Health. SMS offers the nation’s only Ph.D. level training in both public
health and multiple social science disciplines, preparing students to conduct rigorous, high-impact research on
historical, social, cultural, and psychological dimensions of gender and sexuality as they impact reproductive
and sexual health and the health of gender and sexual minorities, both nationally and globally. Nationally,
sexual and reproductive health indicators continue to lag behind those of other developed countries, with
substantial racial disparities both in HIV and in maternal mortality. Gender and sexual minorities experience
especially high rates of serious physical and mental illness. Globally, the burden of disease and death associated
with HIV, sexually transmitted infections, and maternal and infant mortality represent urgent problems. This
application requests funding for 5 trainees. We guarantee funding for up to 5 years, but the majority of trainees
secure other external funding for their dissertation work. The program has a strong track record of success in
terms of trainee diversity, productivity, and post-graduate accomplishments: all 12 trainees appointed to this
program who have earned PhDs continued on to careers in biomedical research.
Trainees follow a theoretically and methodologically rigorous curriculum consisting of (1) disciplinary
training in anthropology, sociology, psychology, or history comparable to that received by Ph.D. candidates in
Columbia’s Graduate School of Arts and Sciences; (2) a two-semester course in the major traditions in social
theory that undergird contemporary research and practice in the sociomedical sciences; (3) epidemiology and
biostatistics; (4) a minimum of two additional courses on contemporary theoretical approaches and substantive
topics in gender, sexuality, and health; (5) an ongoing faculty-trainee seminar in gender, sexuality, and health;
(6) a required course in research ethics and responsible conduct of research; (7) a research apprenticeship with
program faculty; (8) doctoral research on a topic in gender, sexuality, and health. This program’s highly-
accomplished training faculty are drawn from the fields of Sociology, Anthropology, History, Epidemiology,
Population and Family Health, Economics, Bio-behavioral Sciences, Pediatrics, Obstetrics and Gynecology,
Nursing, Emergency Medicine, Neurology, Psychiatry, and Social Work. Innovations in this application include
new NICHD-funded training faculty, enhancing the program’s already strong alignment with NICHD-wide
research priorities including maternal and child health, as well as Population-Dynamics- Branch-specific
priorities (contraceptive use and non-use, HIV/AIDS).

Public health relevance
PROJECT NARRATIVE Nationally, sexual and reproductive health indicators lag behind those of other developed countries, with striking disparities in maternal health. Gender and sexual minorities confront disproportionate physical and mental health risks. Globally, the burden of disease and death associated with HIV, sexually transmitted infections, and maternal and infant mortality represents an urgent problem. This proposal requests continued funding for a rigorous doctoral program with an outstanding record of success in training young scholars in the methodological and analytical skills needed to conduct high-impact research on these critical public health issues.